Characterization of plasma virome in people who inject drugs to identify early transmission networks of HIV and other bloodborne infections

There is an urgent need for implementing innovative methods to combat the resurgence of HIV and
hepatitis C virus (HCV) infection among people who inject drugs (PWID). The opioid epidemic in the United
States threatens to undermine national 2030 elimination goals for both viruses. While tertiary prevention
strategies have facilitated to a certain extent in improving health outcomes it has been difficult to interdict
transmission of infectious diseases. Moreover, bloodborne infections like HIV and HCV have no symptoms on
initial infection, and thus the beginning of an epidemic can predate the recognition of the first diagnosed case
in the community. In addition, surveillance is also hindered by disincentives for “self-report” caused by
stigmatization and criminalization. We propose using plasma virome components shared between subjects due
to intravenous injection of illicit drugs for early identification of transmission networks in PWID.
Transmission studies have shown that HCV precedes HIV infection in PWID, and hence new HCV
infections serve as strong predictors of communities at risk for HIV. We now ask if there are virome
components that are shared before HCV transmission in PWID. Our hypothesis is that viruses of unknown
pathogenicity will accumulate in blood before HIV or HCV infection and that they will be transmitted by injection
drug use such that their sequences reveal those epidemiological linkages. We will first confirm our preliminary
observations made in our Baltimore cohort using molecular and serology assessments in another PWID cohort
from San Francisco. Like the Baltimore cohort, the San Francisco cohort allows access to plasma samples
before, during, and after acquisition of HCV infection. We will compare plasma virome between age and
gender matched twenty HCV positive (HCV+PWID) and twenty HCV negative (HCV-PWID) PWID. Plasma
from two time points covering the same duration of follow up between the two groups will be tested. The
HCV+PWID will be tested before and during acquisition of HCV. Differences will be determined by
enumerating viral infections between the groups at both time points. The plasma virome will then be
characterized further by NGS using Oxford Nanopore after viral target enrichment. The long reads allow
identification of viral strains (haplotype) suitable for phylogenetic studies. We will characterize the plasma
virome in subjects from the Baltimore cohort (n=10) known to share (linked) HCV sequences. In addition, we
will sequence the same subjects before HCV acquisition to identify shared (linked) virome sequences before
HCV acquisition. Similar sequence characterization of plasma samples from the San Francisco cohort (n=10)
will also be done at two time points. Sequencing both cohorts further validates the approach since no
sequence sharing (linkage) of the virome components should be observed between the two cohorts.
By using routinely collected samples, this work could transform the research of drug use networks and
change public health surveillance of HIV, HCV, and expose occult dynamics of reinfection and superinfection.

Public health relevance
This R21 proposes the use of plasma virome for early identification of HIV and HCV transmission networks among people who inject drugs (PWID). This is of value for public health surveillance as it will help to interdict transmission of bloodborne infections and also expose otherwise occult dynamics of reinfection and superinfection.